Junctophilin-2 cleavage in ischemic heart disease

PROJECT SUMMARY / ABSTRACT
Ischemic heart disease is a major cause of death in the United States. At the cellular level, myocardial
ischemia alters excitation-contraction coupling and promoted the development of heart failure. Junctophilin-2
(JPH2) is an inter-membrane linker protein that maintains the plasmalemma and sarcoplasmic reticulum (SR)
at a fixed distance to facilitate excitation-contraction coupling. Ischemia/reperfusion injury and ischemic heart
disease lead to a loss of JPH2 protein levels, which in part is caused by proteolysis by the Ca2+-sensitive
enzyme calpain. Our long-term goal of this project is to elucidate the molecular and cellular mechanisms by
which calpain causes JPH2 cleavage and how the ensuing JPH2 C-terminal peptide alters myocardial function.
We will test the central hypothesis that calpain cleaves JPH2 to release a C-terminal peptide that traffics into
the cardiomyocyte nucleus where it alters CaMKII-d splicing which affects myocardial remodeling.

Public health relevance
PROJECT NARRATIVE The proposed work will elucidate how proteolytic fragments derived from juncophilin-2 contribute to cellular remodeling associated with the development of ischemic heart disease.